Administrative management of Mount Sinai PD consortium

Summary (Admin Core)
The primary goal of the P20 Administrative Core (Admin Core) is to provide the central support to all activities of
the research, administration, finance, and communications among the three feasibility research projects and
collaboration with other intramural research departments and institutes. The Admin Core will integrate
administrative management for the investigators in the P20 that are based in The Mount Sinai Hospital (main
campus) and Mount Sinai-Beth Israel (downtown). It serves as a hub for communication with PD clinical and
research community at Mount Sinai Health system. Furthermore, the Admin Core aims to establish
organizational basis for a future NINDS Udall Center application. The specific aims include 1. Planning and
management of research activities; 2. Compliance administration of the Center operations and data sharing; 3.
Management of human subject recruitment and data sharing; 4. Coordination of efforts and timelines in the
preparation of Udall Center application.

Public health relevance
Project Narrative No Project Narrative included per RFA-NS-20-002